A germline- and promoter-independent strategy to gain access to all cell types in the brain

Project summary
The heterogeneity from the vast number of cell types in the brain presents a major challenge in our understanding
of how brain works and in our treatment of neurological disorders. With the amazing advances in high throughput
sequencing technology, our knowledge on the molecular makeup of the myriad cell types in the brain has
reached an unprecedented level. However, tools that allow us to easily study the functions of any cell types of
our choice are lagging. The goal of our proposed research is to develop technology to generate such tools. In
order to target a specific cell type, current approaches typically depend on genetically modified animal models,
which is laborious, costly, and low throughput, or well-defined and small cell-type-specific promoters, which still
remain to be difficult to isolate. Here we propose to develop an AAV-based Cell-Type-Specific Targeting
(ACTSTar) system to enable easy access to any cell type in the brain in any species that is independent of
germline modification and promoter isolation and characterization. We plan to generate a library of ACTSTar
drivers to target 50 different brain cell types in the mouse and marmoset. In addition, to reduce off-target
integration and neuroinflammation associated with long-term Cas9 expression, especially in long-term
experiments in primates, we will develop a novel AAV-capsid mediated Cas9 mRNA delivery system for transient
Cas9 expression. This project will generate the much-needed tools for easy access to any brain cell types in
multiple species. Our research goal will be facilitated by the complementary expertise of the MPI team in genome
editing and developing safe Cas9 delivery methods (Lu), neural circuit functions of the mouse brain (Lin), and
visual functions using non-human primates (Hu).

Public health relevance
Project narrative This technology development project attempts to develop a germline- and promoter-independent method to generate recombinase drivers so that any types of brain cells from any mammalian species can be accessed based on specific gene expression. This technology will provide the badly needed technology for the study of cell functions in the brains, especially in non-human primates.